Probing the Rules of Protein Structure-Function Relationships through the De Novo Design of Functional Proteins

Project Summary
The accurate design of de novo proteins with predetermined structural features that enable their function is the
ultimate test of our understanding of protein structure-function relationships. Here, we propose to enhance our
understanding of these relationships through the de novo design of stimuli-responsive protein masks that serve
as protein delivery vehicles for cell penetrating peptides (CPPs), and antimicrobial peptides (AMPs). These
membrane active peptides were chosen as while they have great promise as therapeutic agents, their promise
is unrealized because they lack tissue specificity and suffer from inherent low half-life and stability. To overcome
these obstacles, and in the process gain important insights into protein structure-function relationships, I propose
to develop the Enfolding Pipeline which will mask target peptides in a de novo protein (an Enfold), which would
“unmask” only in the presence of an environmental or disease-specific cue. The first “unmasking” mechanism
will be the introduction of protease cleavable loops between the mask and target peptide, such that the target
peptide will be conditionally released upon cleavage by extracellular proteases that are up-regulated in disease
state. Importantly, we will incorporate three design approaches into this pipeline (ii) parametric protein design
and (iii) newly developed diffusion-based generative models. Molecular dynamics simulations will be
incorporated to tune the stability of the Enfolds, thus accounting for both stability and dynamics, a long-standing
goal in the field. This will allow us to compare each design approach, an important benchmark in the field of
protein design. In Aim 1 we will develop and test this pipeline towards the design of Enfolds for both AMPs and
CPPs. We will characterize the folding, stability and structure of the Enfolds and carry out in vitro cleavage
experiments. In Aim 2 we will characterize the biological activity of the Enfolds and released target peptides.
This will include antimicrobial assays such as MIC and Live/Dead analyses for the AMP Enfolds and, together
with our collaborator Prof. Xiaokun Shu, we will evaluate the ability of Enfolds to conditionally release the masked
CPP, attached to various cargo molecules, via cell-based assays. The results of the first Aims will allow us to
correlate protein structure to function, and will be utilized for the iterative design of the masks. In Aim 3 we will
extend the functionality of the Enfolds to include new mechanisms of “unmasking”. To improve delivery
specificity, we will incorporate receptor targeting peptides such as integrin-specific peptides or GPCR ligands.
As receptor mediated endocytosis is common when targeting these receptors, we will incorporate endosomal
escape mechanisms in the form of either (i) cathepsin cleavable loops between the mask and target peptide as
these proteases are over expressed in endosomes, or (ii) packing of the bundles with pH sensitive residues (e.g.
histidine) that will reduce the stability of the Enfolds in the low endosomal pH. This function-directed approach
expands our fundamental understanding of protein structure-function relationships and our ability to accurately
design protein-peptide interactions, and addresses critical pitfalls in the use of bioactive peptides as therapeutics.

Public health relevance
Project Narrative The design of proteins with functions not yet seen in nature is a fundamental goal in protein science, with many translational applications. This proposal aims to extend our emerging capabilities in functional protein design, through the design of de novo protein drug delivery vehicles, tailored to the structural and physicochemical characteristics of a masked bioactive peptide, with multiple layers of controlled and triggered release capabilities. This function-directed approach will allow us to obtain atomic-level understanding of protein structure-function relationships and protein-peptide interactions, and establish innovative design principles which could ultimately contribute to the development of protein-based therapeutics.